Deciphering the Role of Non-Coding RNAs in Gene Regulation

Abstract:
Nearly half of the world’s population lives in countries where malaria is endemic. Plasmodium falciparum, the
causative agent of the most severe form of human malaria, is responsible for 95% of malaria deaths worldwide.
The main goal of this project is to identify the molecular factors that control chromatin organization and
gene regulation in P. falciparum with a specific focus on long non-coding RNAs (lncRNAs). We will
elucidate the importance of lncRNAs in parasite development, virulence, and sexual differentiation, and
determine whether they can be targeted by novel therapeutic intervention. The proposed research builds
upon a large body of work generated in the PI’s lab that discovered how 3D genome organization and epigenetic
state regulate transcription, parasite development, and sexual differentiation. Despite significant progress in
elucidating mechanisms controlling transcription in the human malaria parasite, the exact molecular components
underlying changes in epigenetics and chromatin structure remain to be elucidated. The studies proposed here
will examine how lncRNAs, together with proteins control epigenetics and chromatin structure, and ultimately
parasite development, virulence, survival, and sexual differentiation. The project is organized into two Specific
Aims. In Aim 1, we will use two complementary methodologies called ChAR-seq and RADICL-seq to identify
patterns of genome-wide RNA and DNA interacting complexes for different classes of transcripts in intact nuclei
at different stages of the parasite life cycle. Results from these experiments together with a complementary set
of molecular approaches, will not only identify stage-specific RNA-chromatin interaction occupancies but also
determine their potential roles in the establishment of chromatin structure and transcriptional regulation. In Aim
2, we will identify the functions at the mechanistic level for candidate lncRNAs that we already identified as
potential regulators of antigenic variation and sexual differentiation. For this aim, we have developed a set of
molecular, cellular, and genome-wide approaches including the use of complementary CRISPR-Cas
technologies, to determine the biological relevance of lncRNAs in the formation and maintenance of epigenetic
features and heterochromatin, as well as the sexual development. It is anticipated that the proposed research
will offer groundbreaking insights into parasite-specific lncRNAs and their role in controlling parasite biology.
Results from this application will most likely lead to novel directions in malaria research and therapy.

Public health relevance
Project Narrative: Progression of malaria parasites through their life cycle is controlled by the way chromatin structure and epigenetics modulate gene expression. In this application, we developed state-of-the-art complementary approaches to identify RNAs that regulate epigenetic, genome architecture and gene expression in the human malaria parasite, Plasmodium falciparum, throughout its life cycle. The proposed study will offer groundbreaking insights into parasite biology and identify novel strategies to kill the parasite.